REPTOR: accelerating antibody discovery and improving hits with machine learning

Antibody therapeutics are becoming increasingly important across a broad range of
indications, yet their development requires discovery from a variety of difficult sources.
Traditional technologies are over four decades old, while newer single-cell approaches for
mining survivors are gaining traction in the wake of the SARS-Cov2 pandemic. However, all
mainstream discovery approaches significantly limit the sampling of the in-vivo antibody immune
response, thereby potentially missing important therapeutic candidates. Approaches to better
deconvolute the antibody response with high-throughput sequencing technologies have begun
to be applied for research uses. However, using these large-scale data to directly perform
antibody discovery has remained elusive.
We aim to develop software to streamline the incorporation of high-throughput
sequencing into the three mainstream discovery approaches, thereby reducing time and
increasing discovery success rate. These software-enabled enhancements will cover
high-throughput sequencing for hybridoma discovery, enhanced enrichment analysis for display
methods, and simplified workflow analysis for popular single-cell methods. The same type of
repertoire sequencing can then be used in a different context to improve candidate antibodies
by leveraging the natural improvements the host individual’s immune system has already
discovered. This expansion of existing candidates is enabled by the deep sequencing of
antibody repertoires using next-generation sequencing technology that provides a window into
the natural antibody evolution and optimization. These newly deep repertoires are able to be
exploited by novel algorithms for analyzing the large antibody families produced, as well as
advances in deep learning that enable large amounts of unlabeled data to be synthesized and
used for model training to search both across antibody families for similarities, as well as within
those families.

Public health relevance
Therapeutic antibody drugs are discovered using a small number of approaches that do not sample the full antibody population in an individual. Deep sequencing of the antibody repertoire can help improve and find new therapeutic candidates with the aid of novel algorithms and deep learning models.